Promoting Prosocial Behavior in Syndromic Intellectual and Developmental Disabilities

Project Summary/Abstract:
The enormous impact of COVID-19 service disruptions on individuals with intellectual and developmental
disabilities (IDDs) has highlighted the critically urgent need to increase access to mental and behavioral health
services. Within IDD populations, genetic syndromes associated with IDDs (“syndromic IDDs”) represent a
particularly vulnerable subgroup. Many patients with syndromic IDDs present with medically complex
phenotypes and remain minimally verbal even into adulthood, creating challenges accessing and benefiting
from community-based interventions. Several reports point to extreme behavior and communication challenges
as the most pressing behavioral health concerns for this population. Our near-term goals seek to identify
effective approaches to target the more severe cognitive and behavioral phenotypes found in syndromic IDDs.
Here, we propose adaptations to function-based treatment (FBT) – an already well-established, person-
centered applied behavior analysis (ABA) model focused on replacing challenging behaviors with prosocial
communication and behavior responses. Using the Planned Adaptation approach, proactive adaptations to
improve the fit of FBT with the syndromic IDD population include syndrome-specific characterizations to inform
phenotype-environment interactions, systematic screening for automatically reinforced behaviors which are
often excluded from published FBT approaches, and adjustments to support minimally verbal individuals. This
proposal draws upon the expertise of the investigative group in syndromic IDDs, conventional and telehealth
behavioral interventions, and implementation sciences to evaluate the adapted, parent-implemented, telehealth
FBT model for syndromic IDDs (FBTsIDD). The goal of this fully remote hybrid type 1 effectiveness-
implementation study is to test FBTsIDD as delivered by non-specialist providers housed in medical hubs serving
individuals with syndromic IDDs. Aim 1 involves a 24-week randomized control trial (RCT) that will randomize
80 children (ages 2 to 12 years) with syndromic IDDs and moderate to severe intellectual disability (ID) and
their caregivers and randomize them into FBTsIDD or positive-parenting treatment (Treatment as Usual, TAU).
Our overarching hypothesis is that FBTsIDD will be associated with significant reductions in challenging
behaviors compared to TAU on independent evaluator ratings using a consumer-driven, Parent Target
Problems (PTP) inventory and standardized measures of behavior and functional communication. Aim 2 seeks
to systematically measure and understand both planned and unplanned adaptions to FBTsIDD using the
Framework for Reporting Adaptations and Modifications-Expanded (FRAME). Together, these aims provide an
innovative model to develop effective, acceptable, and scalable interventions for behavioral and
communication challenges across the diverse, vulnerable population of individuals with syndromic IDDs.

Public health relevance
Project Narrative Extreme behaviors and communication challenges contribute to functional impairments across nearly all aspects of daily life for individuals with intellectual and developmental disabilities (IDD), exacerbating preexisting health inequalities. This study seeks to adapt a telehealth parent-implemented challenging behavior intervention for delivery through medical hubs serving complex, severely affected genetic syndromes associated with IDD. The tailoring and scaling of evidence-based behavioral interventions for syndromic IDDs provides a compelling model to provide timely and accessible care for these complex conditions during periods of service disruption, such as the COVID-19 pandemic, as well as for families living in traditionally underserved and/or under resourced communities.